Measuring NICU Nurse Practitioner Workload in Real-time to Improve Care Quality and Patient Safety

PROJECT SUMMARY
High provider workload is a threat to care quality, patient safety, and providers’ well-being and job
satisfaction. Workload – which lacks a universally accepted definition - is a complex multi-dimensional
construct that is affected by external task demands and environmental, organizational, and psychological
factors. The importance of managing high workload is nowhere more evident than in neonatal intensive care
units (NICUs). Critically ill neonates are highly vulnerable to iatrogenic events due to their immaturity and
fragility, and high clinician workload has been directly associated with increased incidence of adverse neonatal
safety outcomes.
Despite the evidence and need, patient safety researchers have been slow to develop multi-level models,
scalable workload measurement systems, or other health information technology interventions to improve
workload management and patient safety. Conventional workload management tools predominantly measure
and predict workload using unit-level (e.g., staffing ratios) or patient-level (e.g., acuity) data rather than data
collected across the four levels of workload recommended by human factors engineers (HFEs) - unit, job,
patient, and situation. As a result, current tools under-measure the workload experienced by providers and are
not designed to identify mutable microsystem factors that contribute most to provider workload.
A promising development in workload research is the increasing emphasis on measuring situational
workload which best explains the workload experienced by clinicians due to healthcare microsystem design.
Situational workload is most affected by performance obstacles (i.e., delays, interruptions, etc.) in the local
work environment and can be applied at the unit, job, or patient-levels. Most importantly, it is diagnostic of
underlying contributory factors and therefore actionable for improvement. To date, situational workload has
been measured using subjective surveys which are work-interrupting, thus difficult to integrate into practice.
Vanderbilt University Medical Center (VUMC), in collaboration Johns Hopkins University (JHU),
will employ a systems engineering human-centered design process to design, develop, and validate
new multi-level model of NICU nurse practitioner workload derived from readily accessible electronic
health record (EHR) data. The validated model will be the foundation for a future EHR-based clinical
decision support (CDS) tool that will track the real-time workload of NICU providers, predict near-
term future unit workload, and guide workload reduction and balancing interventions. The project’s
three Specific Aims are: Aim 1. To conduct a comprehensive HFE-based analysis of NICU provider
(i.e., neonatal nurse practitioner) workload; Aim 2. To design and develop real-time multivariable
workload models and Aim 3. To validate the real-time workload models at VUMC (A) and to
determine the generalizability of the models at an external hospital (B).

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because it aims to improve the quality and safety care delivered by providers in neonatal intensive care units (NICUs). The research is significant because it will improve neonatal patient safety by changing the way NICU provider workload is measured and used for workload management, organizational learning, and improvement. The project is innovative because it will use data readily accessible in electronic health records to develop a new multi-level model of workload for neonatal nurse practitioners and use this model to guide the design and development a future clinical decision support tool for provider workload management and safety improvement.